Teaching Obesity Treatment Options to Adult Learners (TOTAL): A Multi-site RCT

Background: Nearly 80% of Veterans meet criteria for overweight (body mass index [BMI] of 25-29.9 kg/m2) or
obesity (BMI≥30). VA offers three evidence-based obesity treatments at little to no cost to Veterans: MOVE! (to
improve dietary intake and physical activity through behavioral modification); obesity medications; and bariatric
surgery, but all are significantly underutilized: <10% of Veterans with obesity participate in MOVE!; 2% receive
obesity medications; and 0.3% of those who meet BMI criteria for bariatric surgery (BMI≥35) undergo it. There
is an urgent need to increase use of all three treatments to improve Veteran health.
Significance/Impact: Nearly 4,000,000 Veterans meet BMI criteria for overweight/obesity. It is essential that
Veterans with overweight/obesity are aware of the three treatment options and are motivated to pursue them.
Currently, no interventions in VA seek to increase use of all three evidence-based obesity treatment options for
Veterans not currently participating in MOVE!. The TOTAL intervention (Teaching Obesity Treatment Options to
Adults Learners), if effective, would increase obesity treatment initiation for Veterans, lead to greater weight loss,
and improve quality of life. Given that TOTAL is deliverable via VA telemedicine, it could be implemented
throughout the VA healthcare system without requiring significant resources and could be integrated into the
existing VA behavioral weight management program, MOVE!.
Innovation: The research in this proposal would be the first adequately powered RCT in VA testing an
intervention to increase use of all three evidence-based obesity treatments: MOVE!, obesity medications, and
bariatric surgery. It would leverage the power of the VA electronic health record and would improve access to
care by expanding use of a recently developed telemedicine technology – VA Video Connect (VVC) – which was
developed by VA researchers. It could be implemented and disseminated efficiently within VA given that MOVE!
is available at every VAMC and is supported by NCP.
Specific Aims: Aim 1: Compare the effectiveness of TOTAL vs. usual care for increasing obesity treatment
initiation among Veterans with overweight/obesity who are not participating in MOVE!; Aim 2: Compare the
effectiveness of TOTAL vs. usual care for increasing sustained MOVE! participation, receipt of an obesity
medication prescription or bariatric surgery referral, and weight loss; Aim 3: Inform future dissemination efforts
of TOTAL via interviews with key stakeholders, a “Reach” analysis, and cost analysis.
Methodology: Study population: Veterans at two VAMCs, age 18-75 with a BMI ≥30 or 27-29.9 + an obesity-
related comorbidity who have not had a MOVE! visit within the past 12 months and thus are not participating in
obesity treatment will participate in the RCT; Intervention: The TOTAL intervention consists of an 18-minute
obesity treatment educational video and three motivational sessions (all delivered via VA Video Connect [VVC]);
Comparison: Usual care (Veterans who have not had a MOVE! visit in the previous 12 months); Outcomes:
MOVE! initiation, sustained MOVE! participation, obesity medication use, bariatric surgery referral, weight
change; Timing: Primary and secondary outcomes will be measured 18 months post-randomization.
Implementation/Next Steps: Facilitators and barriers to TOTAL implementation will be assessed in Aim 3
interviews with Veteran, provider, and operations stakeholders using the Consolidated Framework for
Implementation Research (CFIR). [We will also perform “reach” and cost analyses. We will collaborate with NCP
to disseminate TOTAL to all VAMCs that have a MOVE! program. The National MOVE! Director will present
study results on a national MOVE! call and make presentation materials available on the national MOVE!
SharePoint dissemination site. The National MOVE! Director will support MOVE! coordinators who work directly
with health behavior coordinators at every VAMC with MOVE!. The study team will consider partnering with NCP
to conduct a QUERI National Partnered Evaluation evaluating how TOTAL can be implemented throughout VA.

Public health relevance
Nearly 8 in 10 Veterans meet criteria for overweight/obesity. Three evidence-based treatment options are available within VA (behavioral weight management [MOVE!], obesity medications, and bariatric surgery). However, all treatments are significantly underutilized. This study will evaluate the effectiveness of a novel intervention designed to increase obesity treatment initiation and subsequently weight loss within VA. The intervention, Teaching Obesity Treatment Options to Adult Learners (TOTAL), involves an educational video and multiple motivational sessions delivered via telemedicine. If effective, TOTAL could be implemented throughout VA without requiring significant resources and could be integrated into the existing VA behavioral weight management program, MOVE!, which is present at nearly every VA medical center.